Cellular and molecular delineation of pathologic fibroblasts in pulmonary fibrosis

PROJECT SUMMARY
Pulmonary fibrosis is a chronic and intractable disease with a 5-year survival rate comparable to pancreatic or
lung cancers. Deterioration of respiratory function in pulmonary fibrosis is caused by progressive replacement
of normal tissue for gas exchange to dense fibrotic scar with fibrillar collagens. Pathologic fibroblasts
accumulate at the sites of fibrogenesis and work as effector cells for excessive collagen deposition.
Development of therapeutic strategies for targeting pathologic fibroblasts is hindered by the lack of
understanding to cellular lineage and molecular detail of pathologic fibroblasts. In our previous study, we
performed single-cell RNA-sequencing of normal and fibrotic lungs of mouse and human with a specialized
protocol to identify all collagen-producing cells. We identified several fibroblast subsets that localize in different
compartments of the lung. One of the fibroblast subsets emerge in fibrotic lungs of both mouse and human and
show the highest levels of collagen gene expression and enhanced migratory capacity. These fibroblasts are
characterized by specific expression of Cthrc1 (collagen triple helix repeat containing 1) and localized within
fibroblastic foci of idiopathic pulmonary fibrosis, suggesting their pathologic role in pulmonary fibrosis. We
recently generated and validated a novel mouse strain, Cthrc1-CreER, which allows us to specifically
manipulate the pathologic fibroblast population in pulmonary fibrosis. The goal of this K99/R00 proposal is to
elucidate the role and transcriptional regulations of pathologic fibroblasts in pulmonary fibrosis by using our
innovative murine tools. Aim 1 (K99 phase) will reveal the role and fate of pathologic fibroblasts by ablating
Cthrc1+ cells or lineage-tracing Cthrc1-CreER-labeled cells over the course of bleomycin-induced pulmonary
fibrosis. Aim 2 (K99 phase) will reveal the transcriptional and epigenetic landscape of pathologic fibroblasts by
performing RNA-seq, ChIP-seq, and ATAC-seq of purified Cthrc1-CreER-labeled cells at multiple time points of
pulmonary fibrosis to seek master regulators for activation and deactivation. We will also seek the
transcriptional regulations of CTHRC1+ cells in human pulmonary fibrosis. Aim 3 (R00 phase) will demonstrate
the role of genes regulating pathologic fibroblasts by using intratracheal adoptive transfer of fibroblasts with
lentiviral gene modifications and by conditionally knocking out candidate genes in fibroblasts in pulmonary
fibrosis. These studies using the murine genetic tool highly specific for pathologic fibroblasts will shed light on
cellular function and transcriptional regulations of pathologic fibroblasts in pulmonary fibrosis. This proposal is
also designed to provide the candidate with training opportunity to obtain skill sets for murine genetic approach
in search of therapeutic targets and functional genomics approach integrating RNA-seq, ChIP-seq, and ATAC-
seq. The success of this project will enable the candidate to establish his expertise in the field of pulmonary
fibrosis and lead to the candidate’s transition to scientific independence over the course of award period.

Public health relevance
PROJECT NARRATIVE Pulmonary fibrosis is a devastating disease with few therapeutic options and caused by accumulation of pathologic fibroblasts, which produce excessive amounts of extracellular matrix. Molecular detail of pathologic fibroblasts remained poorly understood due to the lack of specific markers and methodology to investigate them. Here we propose to reveal the function and transcriptional landscape of pathologic fibroblasts by using a recently generated mouse strain, which can specifically target pathologic fibroblasts in pulmonary fibrosis.